Functional characterization of lysosome membrane and its protein quality control system

PROJECT SUMMARY
The lysosome is an important organelle responsible for digesting and recycling materials, nutrient sensing, and
controlling cell proliferation. It is also linked to neurodegenerative diseases, including Alzheimer's,
Huntington's, and Parkinson's diseases. Despite its importance, the regulation of lysosomal membrane protein
composition and the function of its transporters and ion channels are not well understood. My lab has made
significant progress in studying the turnover mechanisms of lysosomal membrane proteins by identifying a
conserved ubiquitin- and ESCRT-dependent pathway for protein degradation. However, several key questions
remain, including the identification of substrates of lysosomal E3 ligases in humans (future direction 1), the
assembly of the ESCRT machinery to the lysosome membrane for internalizing ubiquitinated cargoes (future
direction 2), and identifying other proteins involved in the quality control process. Additionally, there is a lack
of understanding of the substrates, direction of transport, and energy dependence of many lysosomal
transporters and ion channels (future direction 3). My lab has developed a reconstitution platform to study
lysosomal membrane transport proteins, which will be combined with conventional methods such as
metabolomics of isolated lysosomes to better understand these processes.

Public health relevance
PROJECT NARRATIVE This proposed study will investigate the function of lysosomal membrane transporting proteins and lysosomal protein quality control system. Lysosome dysfunction leads to lysosomal storage diseases (LSD, ~70 in humans) and contributes to aging-related neurodegenerative diseases. Our discoveries will shed light on the development of new treatment strategies for LSDs and neurodegenerative diseases.